RAPID ACCELERATION OF DIAGNOSTICS (RADX) TECH PROGRAM: PROJECT NO 5218 MATMACORP SARS-COV-2 HIGH THROUGHPUT LABORATORY CAPACITY SCALE-UP

MatMaCorp is an animal health diagnostics company that collaborates with agencies including the Department of Homeland Security (DHS) Science and Technology group and USDA's Meat Animal Research Center (USMARC). In February of 2020, we shifted focus to human health in response to the COVID-19 pandemic. We are working to utilize our portable diagnostic platform, the Solas 8 fluorescent detection device and proprietary tests, with features supportive of rapid, mobile human diagnostics. Our device uses molecular probes to detect and identify specific DNA or RNA (target) sequences, in addition to a mutation or variation (SNP) within a sequence. Additional Features: Â· Touchscreen interface Â· USB Ports Â· Wi-Fi enabled Â· Mobile Application Â· Automated calling of results Additionally, our assays are lyophilized and do not require pipettes, centrifuges, or refrigeration and have a twelve-month shelf life. The Covid-19 kits are made for lab-use or field-use, providing flexibility and accessibility. Whether at a workplace, in a lab, or in a mobile testing center, results can be generated in real-time without specialized lab equipment, technical skills, or controlled conditions.